Tracking Intracellular Pathways to Abeta Generation

ABSTRACT Amyloid-beta (Aβ)?the principal component of amyloid plaques in Alzheimer’s disease (AD)?is generated by sequential secretase cleavages of the amyloid precursor protein (APP), a type 1 transmembrane protein. Despite three decades of study, the precise subcellular locations of Aβ generation have remained elusive. This is important because not only is Aβ central to AD pathogenesis but reducing Aβ levels has been a major focus in the development of potential AD therapeutics. Determing the precise cellular locations of Aβ generation has been a major bottleneck because current model systems are incapable of tracking Aβ peptide in living cells. We have recently developed a novel APP construct which incorporates an unnatural amino acid in the extracellular Aβ segment of APP, enabling click-chemistry to attach a small molecule fluorophore to Aβ at the plasma membrane. Coincident attachment of distinct fluorescent proteins to intra- and extracellular regions of APP allows the real-time visualization of APP trafficking and Aβ generation in living cells. In this application we will exploit this model system to determine the impact of retromer sorting on APP trafficking and Aβ generation in engineered neural cell lines (Aim 1) and to determine the temporal-spatial dynamics of APP trafficking and Aβ generation within primary neurons (Aim 2). At the completion this grant, we will have a basic understanding of the itineraries of APP that lead to Aβ generation. We will also be able to examine these same pathways in primary neurons (or even iPSCs), and study how these Aβ-generating pathways may be altered by genetic variants or neuronal activity.

Public health relevance
PROJECT NARRATIVE A hallmark of Alzheimer’s disease brains is amyloid plaques composed primarily of amyloid-beta peptide generated and released from affected neurons. Current therapeutic strategies focus on reducing extracellular amyloid-beta but little is known about cellular mechanisms controlling where the peptide is generated in living neurons. In this proposal we will use a novel method we developed to specifically address this question. Results from our studies may lead in the future to better strategies to control Alzheimer’s disease.